Defining the Contribution of Placental Macrophage Polarization and Iron-Handling to the Progression of Gestational Diabetes Mellitus

? DESCRIPTION (provided by applicant): Gestational diabetes mellitus (GDM) is the most common metabolic disorder during pregnancy causing considerable morbidity and long-term complications for both mother and child. A major barrier to reducing the incidence and burden of GDM is a lack of clarity regarding the underlying pathophysiological mechanisms contributing to the pathogenesis and severity of the disease. Although aberrant systemic inflammation has been associated with GDM, the factors that contribute to this inflammation have not yet been elucidated. Macrophages are known to play an extensive role in regulating both systemic and local inflammatory environments as well as being responsible for 80% of the Iron (Fe) availability within the body. Macrophages couple polarization status and inflammatory responses to Iron-handling and availability. For example, pro-inflammatory macrophages sequester Fe while anti-inflammatory macrophages adopt an Iron- cycling phenotype resulting in increased Fe release. Exclusively expressed on macrophages and used as a marker of placental macrophages (pMφs), CD163 mediates the endocytosis and subsequent breakdown of hemoglobin-haptoglobin (Hb:Hp) complexes initiating a heme-oxygenase-dependent anti-inflammatory signaling pathway. Despite these well-known associations, little is known regarding the interactions between Fe and pMφs within the placenta. In this proposal we will compare GDM and healthy placentae in terms of pMφ inflammatory profile and Fe status. Surprisingly, little work has been done to investigate how GDM alters pMφ phenotypes and placental inflammation, especially in terms of Iron-handling. We hypothesize that (i) pMφs isolated from human and murine healthy placenta display anti-inflammatory characteristics and are actively engaged in Iron-handling in contrast to subjects with GDM where pMφs accumulate Fe and display a pro-inflammatory phenotype (ii) high dietary Fe will increase pMφ Fe accumulation and placental inflammation leading to an increase in the incidence and severity of GDM. We plan to test these hypotheses through a series of integrated Specific Aims. First, we will characterize the Iron-handling status and activation state of human pMφs from GDM and healthy subjects (Aim 1). We will next characterize the Iron- handling status and activation state of murine pMφs in GDM (Aim 2). Finally, we will determine how varying amounts of dietary Fe affect placental inflammation GDM progression (Aim 3). We will define how GDM influences the inflammatory and Iron-handling status of pMφs. Furthermore, these experiments will elucidate the impact of altered dietary Fe levels on the incidence and severity of GDM laying the groundwork for future studies focused on modifying dietary Fe to improve maternal-child health. Together, results from this proposal will lay the groundwork for a better understanding of how GDM affects placental inflammation and the role of iron in the development and progression of GDM.

Public health relevance
PUBLIC HEALTH RELEVANCE: Gestational diabetes mellitus (GDM) is the most common metabolic disorder during pregnancy causing considerable morbidity and long-term complications for both mother and child. The experiments proposed in this application will investigate the impact of placental inflammation and dietary iron in GDM incidence and severity. These studies will characterize placental macrophages and their contribution to the placental inflammatory environment and elucidate the impact of dietary iron on GDM, allowing for a better understanding of this complex disease.